The role of geometric structure in avoidance of oxygen rebound to enable aliphatic halogenation and oxacyclization by non-heme Fe(IV)-oxo (ferryl) complexes

Abstract of Parent Award: (R01 GM141284 “The role of geometric structure in avoidance of
oxygen rebound to enable aliphatic halogenation and oxacyclization by non-heme Fe(IV)-oxo
(ferryl) complexes”)
Iron(II)- and 2-(oxo)glutarate-dependent (Fe/2OG) oxygenases catalyze hydroxylation,
halogenation, cyclization, dehydrogenation, and stereoinversion of aliphatic carbon centers, C–
H-bond-activation reactions that collectively represent a holy grail of synthetic chemistry.
Biosynthetic pathways to important natural-product drugs are replete with these enzymes, and
the pharmaceutical industry is beginning to leverage evolved versions of Fe/2OG oxygenases as
biocatalysts for "green" processes to their synthetic drugs. Recent studies of Fe/2OG
hydroxylases, halogenases and cyclases by the Penn State group show that the disposition of the
substrate relative to the common iron(IV)-oxo (ferryl) and iron(III)-hydroxo/substrate-radical
intermediates may be crucial for control of reaction outcome. On the basis of data available so
far, we hypothesize that the structural rearrangement of the metallocofactor rather than the
substrate positioning is the primary factor directing regioselectivity. Therefore, in this work, we
will perform spectroscopic characterization of faithful reactive-state analogs to gain first-hand
insight as to how the individual enzymes adjust the structure of the active complex and to
uncover common modes that direct reactivities in the superfamily of Fe/2OG oxygenases. In this
project, we will innovate and deploy a suite of novel intermediate mimics and spectroscopic
probes/methodologies to resolve the geometries of the key intermediate states in the
pharmaceutically relevant subclasses of Fe/2OG enzymes. Our elucidation of how the cofactor
structures and relative dispositions of the substrates dictate the divergent outcomes will inform
efforts to discover novel members of this superfamily and assign their phenotypes. Ultimately,
information obtained in this project will be instrumental in developing new biocatalysts for drug
synthesis.

Public health relevance
Project Narrative Non-heme-iron and 2-oxo-glutarate-dependent enzymes perform an incredible array of oxidative transformations in biosynthetic pathways of medicinal natural products. This project seeks to understand which structural factors allow the metallocofactor in these enzymes to perform various reactions. Uncovering this knowledge will unlock the opportunities for bioengineering these enzymes for novel drug synthesis and develop innovative bio-inspired chemical processes.